Acquiring a GPU server to accelerate developing deep learning methods to reconstruct protein structures from cryo-EM data

Project Summary
The goal of this supplement is to acquire a Dell high-performance computing server with 8 Nvidia A100 Graphics
Processing Units (GPUs) to accelerate the development of deep learning methods to reconstruct protein
structures from cryogenic electron microscopy (cryo-EM) image data accurately and automatically. The cryo-EM
technology can determine the quaternary structure of large protein complexes and assemblies consisting of
many chains that are difficult or even impossible for traditional techniques such as X-ray crystallography or
nuclear magnetic resonance (NMR) to determine. As the cryo-EM technology routinely reached high resolution
in recent years, it has been revolutionizing the field of structural biology and widely used to determine structures
of large protein complexes and assemblies. However, the computational reconstruction of protein structures from
cryo-EM image data is still a time-consuming and labor-intensive process. The advanced artificial intelligence
(AI) methods such as deep learning hold the key to automate the process and improve the reconstruction
accuracy. The parent R01 grant of this supplement aims to develop cutting-edge deep learning models such as
2D and 3D transformers to automate the key tasks of reconstructing protein structures from cryo-EM data: (1)
picking protein particles in cryo-EM images (micrographs); (2) denoising cryo-EM density maps built from protein
particle images; (3) reconstructing protein structures from cryo-EM density maps; and (4) integrating the methods
of (1), (2) and (3) as a pipeline to automatically reconstruct high-accuracy protein structures from cryo-EM image
data without human intervention.
Our substantial progress in the first eight months of this project has demonstrated that the proposed
methods are fully feasible and highly promising. However, training and testing the large deep learning
transformer models on big cryo-EM datasets efficiently and effectively need a large amount of GPU computing
power. Using the current GPU resource available to us, it takes about one year for a developer to complete the
development of one deep learning method. Although the speed can yield significant progress, it is not fast enough
to maximize the potential and impact of the cutting-edge deep learning methods of the parent R01 project. This
supplement will enable us to acquire a high-performance computing server consisting of 8 Nvidia A100 80GB
GPUs to drastically speed up the research in the parent R01 project. This GPU servers can reduce the time of
completing the development of one deep learning model from about one year to less than two months, and
therefore drastically improve the productivity of the developers and greatly accelerate publishing and releasing
the methods and tools developed in this project. Moreover, the large (80GB) memory of each GPU will enable
us to train high-quality deep transformers consisting of millions of parameters to maximize the accuracy of
reconstructing protein structures from cryo-EM image data.

Public health relevance
Project Narrative Cryogenic Electron Microscopy (cryo-EM) is a major technology to determine the structures of protein complexes and assemblies. This project will acquire a Dell high-performance computing server with 8 Nvidia A100 Graphics Processing Units (GPUs) to greatly accelerate the development of artificial intelligence (AI) methods to build protein structures from cryo-EM image data, which will be useful tools to advance structural biology and structure-based biomedical research and technology development.